NATIONAL CANCER INSTITUTE (NCI) INFORMATION TECHNOLOGY (IT) BLANKET PURCHASE AGREEMENT (BPA) - DIGITAL SERVICES AND SOLUTIONS (DSS) FOUNDATIONAL SUPPORT

NATIONAL CANCER INSTITUTE (NCI) INFORMATION TECHNOLOGY (IT) BLANKET PURCHASE AGREEMENT (BPA) - DIGITAL SERVICES AND SOLUTIONS (DSS) FOUNDATIONAL SUPPORT